The effects of power outages on cardiovascular outcomes in New York State

SUMMARY/ABSTRACT
In 2020, U.S. electricity customers faced an average of 8 hours without power, the longest duration on record.
Climate change is expected to cause more severe weather events, which can damage electricity grids and dis-
tribution pathways. Outages may be particularly problematic for cardiovascular health, as they disrupt access to
temperature-controlling tools (e.g., air conditioners, fans). Climate change will also result in higher temperatures,
which can exacerbate cardiovascular disease (CVD). CVD affects 126.9 million American adults and is the lead-
ing cause of death and disability in the U.S., with communities color and socially marginalized communities
disproportionately affected. Understanding the impact of power outages on CVD and how this relationship varies
across community sociodemographic characteristics is central to climate and environmental justice. A critical
research gap remains about the health effects of power outages generally and the extent to which they affect
acute CVD risk. Partly due to the lack of high spatiotemporal resolution measures for outage exposure, most
prior studies have not measured neighborhood-level electricity availability. Additionally, previous studies did not
consider the potential dual threat when outages co-occur with anomalous temperatures or whether certain com-
munities may be particularly vulnerable to the effect of power outages. In particular, we will consider whether
individuals living in communities with higher social vulnerability or more racial/economic segregation experience
worse CVD outcomes after power outages. We will use 2017-2020 New York Statewide Planning and Research
Co-operative System (SPARCS) hospitalization data and 30-minute resolution power outage data within 1,831
power operating units statewide to fill this gap. Using diagnostic codes, we will identify hourly hospitalizations for
the acute cardiovascular outcomes, myocardial infarction and stroke. We plan to implement case-crossover
study designs with conditional logistic models, which inherently control for non-time-varying individual-level con-
founding variables. Our overarching hypothesis is that more outage hours are associated with increased risk of
CVD hospitalizations, particularly during anomalous temperature events, and that there will be disparities in this
exposure-response relationship across area-level vulnerability and segregation. We aim to (1) investigate the
association between power outages and CVD hospitalizations, (2) determine the impacts of exposure to power
outages during anomalously hot and anomalously cold temperature events separately on CVD hospitalizations,
and (3) identify communities vulnerable to the effects of outages on CVD. This research supports the NIEHS
Strategic Plan to evaluate co-exposures and considers issues of environmental justice. Collectively, we will pro-
vide crucial information that can inform future climate adaptation policies to reduce CVD-related morbidity in an
equitable manner.

Public health relevance
PROJECT NARRATIVE This project will advance knowledge about the impact of power outages on cardiovascular outcomes in the context of climate change. We plan to examine the role of power outages on cardiovascular disease, to understand the effects of outages during anomalously hot and anomalously cold temperatures, and to identify communities especially vulnerable to the effect of outages on cardiovascular disease outcomes. Our project can shape approaches to minimize outage-related morbidity and inform equitable preparedness strategies, emergency response, and energy policies.